Neuronal correlates of avoidance and pursuit during human ambulatory navigation

PROJECT SUMMARY/ABSTRACT
Successfully navigating one’s environment requires simultaneous processing of reward seeking and risk
aversion. For example, driving to work or walking through a crowded city center includes reaching spatial targets
in a timely manner while avoiding collisions with stationary and/or moving objects. Spatial processing and
decisions involving avoidance and pursuit are both linked to medial temporal lobe (MTL) structures including the
hippocampus and amygdala, and pathologies within these networks cause altered decision-making patterns.
While the physiological aspects of MTL engagement during avoidance and pursuit have been explored in rodents
and stationary humans, the parallel neuronal mechanisms in freely-moving humans remain entirely unknown.
The proposed study will leverage a unique cross-institutional collaboration, recruiting human participants from a
database of epilepsy patients with acute or chronic implants to record single-unit and local field potential activity
from key regions such as the hippocampus, amygdala, nucleus accumbens, and prefrontal cortex. The project
will also harness cutting-edge wearable technologies, including eye tracking, augmented reality (AR), and motion
capture. Participants will engage in a naturalistic navigation task requiring the pursuit of spatial targets to
earn monetary rewards, all while maintaining a specified distance from an experimenter who is in constant motion
within the environment. The proposed research will identify MTL population oscillatory (Aim 1) and single-
neuron (Aim 2) mechanisms supporting avoidance and pursuit in freely-moving humans. This will allow
for a comprehensive understanding of naturalistic navigation, including aversion to penalties, pursuit of rewards,
tracking the movements of another individual, and the manifestation of behaviors such as freezing. The insights
gained from this research have the potential to guide the development of stimulation-based therapeutic
interventions targeting emotional regulation disorders and other conditions rooted in MTL-related pathologies.
Additionally, the proposed study will pave the way towards understanding the intricacies of human cognitive and
neural processes in complex real-world scenarios, fostering a bridge between fundamental neuroscience and
practical clinical applications. This project will be conducted under the supervision of Dr. Nanthia Suthana and
Dr. Ausaf Bari as part of the UCLA-Caltech Medical Scientist Training Program.

Public health relevance
PROJECT NARRATIVE Real-world navigation frequently involves simultaneous attraction to a goal and aversion to potential risks, and is often impaired in emotional regulation disorders and MTL-related pathologies. However, the MTL oscillatory and single-unit mechanisms underlying avoidance and pursuit in freely-moving humans has not been investigated. This study will utilize mobile neural recording innovations to record deep intracranial activity, eye and body movements, and autonomic activity in human epilepsy patients as they perform an ambulatory task requiring reward maximization, tracking of threats, and continuous decision-making during freely-moving navigation.